Long noncoding RNA-mediated regulation of T-cell alloimmunity

Project Abstract
The goal of this K08 proposal is to provide didactic and experiential training in new techniques needed to
achieve my long-term career goal of developing an independent research program exploring the novel
intersection of long noncoding RNAs (lncRNA) and alloimmunity. The proposed training will allow me to
develop expertise in animal models of hematopoietic stem cell transplantation (HSCT), T cell functional
assays, bioinformatics analysis of next-generation sequencing data sets, techniques to identify lncRNA-protein
interactions, grant writing, mentorship, and laboratory management. This 5-year training plan will be directed
by my primary mentor, Dr. Pavan Reddy, who is an accomplished transplant immunology physician-scientist
with a track record of successfully mentoring junior faculty. I will also be advised by a committee with expertise
in bioinformatics, RNA biology, molecular genetics, and HSCT immunology. The didactic training program
covers bioinformatics, grant writing, advanced immunology, mentorship, and laboratory management.
Allogeneic (allo) HSCT is a curative treatment for high-risk hematologic disorders. Acute graft-versus-host
disease (GVHD) is an allo-T cell-driven major complication of allo-HSCT, for which improved treatments are
needed. LncRNAs control gene expression with tissue specificity and fine-tune immune responses. To identify
potential lncRNA regulators of allo-T cells, we recently performed RNA-sequencing on well-annotated clinical
HSCT samples. This work identified LINC00402 as a novel, conserved, T cell-enriched lncRNA that was
differentially expressed by allo-T cells. Functionally, LINC00402 promoted allo-T cell proliferation. However, it
is unknown if LINC00402 exacerbates acute GVHD in vivo and what molecular mechanisms are responsible
for its effects on allo-T cell function. Based on these prior data and additional new observations, this proposal
will test the overall hypothesis that LINC00402 regulates acute GVHD in vivo by enhancing ERK-c-FOS
signaling in CD4 type 1 (Th1) helper cells. This will be tested using complementary murine and human in vitro
and in vivo systems. Aim 1 will determine the cellular mechanisms of LINC00402 in T cell responses and will
test the specific hypothesis that LINC00402 augments Th1 differentiation and the production of Th1 cytokines
by allo-T cells. Aim 2 will define the molecular mechanisms mediating LINC00402’s regulation of T cells and
will test the hypothesis that LINC00402 directly enhances ERK-c-FOS-dependent T cell receptor signaling. It
will also serve as a training platform to learn bioinformatics analysis of next-generation sequencing datasets
and methods to identify lncRNA binding partners. Aim 3 will elucidate the role of LINC00402 in experimental
acute gastrointestinal GVHD, and will explore the hypothesis that LINC00402 enhances acute gastrointestinal
GVHD by promoting accumulation of Th1 cells. This will be tested using complementary xenogeneic and
allogeneic murine models. Altogether, these studies will explore a unique area of alloimmunity and determine if
LINC00402 is a target for improving allo-HSCT outcomes.

Public health relevance
Project Narrative Acute graft-versus-host disease (aGVHD) is a major complication of allogeneic hematopoietic stem cell transplantation, and improved therapies for aGVHD are needed. To develop potential new targets for improving aGVHD, our group recently identified a novel T cell-enriched long noncoding RNA, LINC00402, that uniquely promotes allogeneic T-cell proliferation. We now seek to determine LINC00402’s function and molecular mechanism in both mice and humans.